Genomic determinants of bronchopulmonary dysplasia development in humans and an animal model

PROJECT SUMMARY .
The purpose of this Mentored Patient-Oriented Research Career Development Award (K23) is to provide Alvaro
Moreira, MD, MSc, Assistant Professor at the University of Texas Health Science Center at San Antonio with the
knowledge and skills requisite to develop into an independent academic physician scientist. His long-term career
goal is to understand the pathologic processes that correlate with the development of bronchopulmonary
dysplasia (BPD), a disease with high morbidity and mortality in premature neonates. To this avail, Dr. Moreira is
incorporating the use of high-fidelity technology to validate two genomic signatures (n=20 genes) that he and his
mentoring team have identified as strong predictors for BPD susceptibility. To achieve this goal, Dr. Moreira and
his mentoring team have devised a comprehensive plan based on: (1) an in-depth hands on training in genomics
and bioinformatics; (2) didactic and experiential instruction in advanced immunology, and (3) rigorous training in
clinical trials. This platform will provide the basis for Dr. Moreira to gain the skills, knowledge and experience
needed to formulate and test incisive hypotheses that will bolster advances in neonatal lung disease. Neonates
diagnosed with BPD are at increased risk for systemic (blindness, mental deficiency) and site-specific
complications (asthma, recurrent respiratory infections, pulmonary hypertension). BPD is characterized by an
aberrant lung development secondary to chronic exposure to hyperoxia and ventilator-induced injury. Despite
advances in neonatal medicine, current therapies are limited and largely ineffective. Thus, there is an urgency
to adopt novel tactics to mitigate and prevent BPD. Significant gaps in understanding the underlying mechanisms
in BPD are attributed to an operational definition, a lack of robust neonatal tissue biorepositories, and animal
models that do not recapitulate the intricacies of human physiology. Translational genomics holds significant
promise as an approach to overcome these barriers. Indeed, in a discovery cohort of 120 preterm neonates, Dr.
Moreira and his mentoring team have identified genomic signatures that predict BPD and stratifies BPD
endotypes in a neonate's first 5 days of life. In this revised application Dr. Moreira plans to validate two genomic
signatures in a large prospective preterm neonatal cohort (Year 1, 2). In Year 3, he will test the ability of a
customized genomic array, based on his signatures, to provide a quick and reliable BPD risk stratification.
Furthermore, Dr. Moreira's studies will evaluate the safety and efficacy of an FDA-approved biologic in a one of
a kind large animal model mimicking BPD. This monoclonal antibody targets a modifiable process found to be
highly predictive for BPD in his genomic profile from the discovery cohort. Dr. Moreira's K23 studies will produce
a rich learning and educational framework directly informing his future R01 proposal aimed at primary prevention
strategies for BPD.

Public health relevance
PROJECT NARRATIVEaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaaa Bronchopulmonary dysplasia (BPD) is the most common lung disease in premature neonates, characterized by long-term respiratory disability, frequent hospitalizations, and high healthcare costs. This proposal will validate a genomic tool that may predict which neonates are at risk for developing BPD. Moreover, we will examine whether an FDA-approved biologic can mitigate genetic changes found to be associated with BPD risk.